Immunoplate-MALDI MS platform and assays

PROJECT SUMMARY
The goal of this proposal is to develop simple, robust and cost-effective Mass Spectrometry (MS)-based
protein assays and platform by combining the best aspects of enzymatic immunoassays – plate based protein
immunoaffinity capture, with the straightforward MS detection offered by MALDI-TOF MS. These immunoplate-
MALDI MS assays are improved version of the enzymatic immunoassays wherein the secondary reporter
antibody detection step is replaced with MS detection, enabling unambiguous protein detection and
identification through specific and accurate measurements of its mass.
The impetus for the development of the new platform and assays is the ability to detect and study human
proteoforms - the different molecular forms in which the protein product of a single gene exist. Mass
spectrometry is uniquely capable of providing measurements of individual proteoforms masses that vary from
the original protein sequence. These proteoforms are best detected intact, which is readily achieved by MALDI-
TOF MS. A MALDI mass spectrum of an affinity–retrieved protein displays all proteoforms captured by an
antibody-coated immunoplate well. Relative ratios of the proteoforms can be determined from their signals in
the mass spectra, and reported as % abundance. The new platform and assays will meet the three key
enabling factors for MS protein assays: content, cost, and simplicity.
In this Phase I research we will demonstrate the platform via proof-of-principle immunoplate-MALDI MS assays
for six protein biomarkers that exhibit proteoforms: apolipoprotein E, transferrin, transthyretin, cystatin C, retinol
binding protein, and B-type natriuretic peptide. These protein biomarkers span a wide spectrum of
concentrations and molecular weights, which will enable us to test the platform range, capabilities and
limitations. Immunoaffinity isolation of the proteins from human plasma samples will be achieved utilizing
antibody-coated 96-well plates, after which the captured proteins and their proteoforms will be eluted and
spotted on a MALDI target for MS analyses. Experimental conditions will be tested for the antibody adsorption,
human plasma assaying, and elution onto MALDI targets. The number of steps will be kept to a minimum, yet
enough to obtain a satisfactory performance at the lowest cost possible. The reproducibility of the new assays
will be evaluated, and the assays will be benchmarked.
Our goal is to develop the immunoplate-MALDI MS platform for the general R&D market. Assay designed on
this platform will be cost-effective and simple, and can readily be adopted by laboratories with existing MALDI
MS instrumentation. The new platform and assays can be used in proteoform discovery efforts, as well as
larger clinical validation studies to delineate the clinical correlations of specific proteoforms.

Public health relevance
PROJECT NARRATIVE The new immunoplate-MALDI MS platform and assays will be cost-effective and simple, and provide the new content of proteoforms detection, facilitating their widespread use and acceptance in proteoform discovery efforts, as well as larger clinical validation studies that will expand our understanding of the role of specific proteoforms in health and disease.